Deciphering the protective effect of the transient marker gene, Dhcr24, in the adrenal gland inner cortex.

Abstract
DHCR24 was first identified as a gene associated with cell aging and cell survival in Alzheimer’s disease. We
recently found that Dhcr24 is transiently expressed in the mouse adrenal gland inner cortex which consists of
aged adrenocortical cells that undergo apoptosis during development. We also found that thyroid hormone,
which controls many developmental processes such as differentiation of retina in mammals and apoptosis during
metamorphosis in amphibians, significantly upregulates Dhcr24 expression in the adrenal gland inner cortex.
Interestingly, this upregulation of Dhcr24 is accompanied by the reduced apoptosis of aged adrenocortical cells.
In this proposal, we aim to use our expertise in the adrenal gland and the next generation sequencing
technique to study the connection between Dhcr24 and the thyroid hormone-mediated antiapoptotic
effect in aged adrenocortical cells. In Aim 1, we will complete the initial phenotypic analysis of the Dhcr24
conditional knockout mice. This will decipher the role of Dhcr24 in the adrenal gland at the histological level. In
Aim 2, we will compare transcriptomes in adrenal glands from Dhcr24 conditional knockout mice and wild type
littermates before and after thyroid hormone treatment. This will identify Dhcr24 downstream genes and
pathways associated with the thyroid hormone-mediated anti-apoptotic effect. Elucidating genes associated with
Dhcr24 will advance our understanding of the Dhcr24-mediated anti-apoptotic effect. Identification of the thyroid
hormone-responsive genes and their connections with Dhcr24 will help to understand how thyroid hormone and
Dhcr24 influence cell survival and aging.

Public health relevance
Project Narrative Dhcr24 has been found to have a cell-protective effect to prevent age-dependent apoptosis. In the adrenal gland, its expression is significantly upregulated by thyroid hormone, which also prevents aged adrenocortical cells from apoptosis. Understanding the connection between Dhcr24, thyroid hormone signaling, and age-dependent cell apoptosis will unveil how thyroid hormone and Dhcr24 influence cell survival and aging.